Network models of differentiation landscapes for angiogenesis and hematopoiesis

My long-term research goal is to develop data-driven mathematical models to understand and control
cell differentiation. My lab’s approach integrates single-cell transcriptomics data in a mathematical model, the
Hopfield model, to describe the signaling dynamics in gene networks and simulate the effect of perturbations on
sets of target genes. Originally developed as a mathematical model of the brain, the Hopfield model allows for a
direct mapping of associative memory patterns into dynamical attractor states in a network, so that the system
can recover a host of memories using partial information. Our rationale for representing phenotypic cell states
as associative memories is that when a cell “decides” to differentiate by expressing a new pattern of genes in a
network, the cell relies on a set of built-in associative memory patterns shaped by evolution. In contrast to many
deep learning and other machine learning methods, representing cellular decision processes using associative
memories provides interpretable information that can integrate pre-existing biological knowledge (e.g., pathway
information) to help elucidate fundamental biological rules. Moreover, the approach goes beyond a descriptive
analysis of single-cell data. It paves the way for in-silico experiments that could identify new drug targets and
generate new hypotheses for pre-clinical and clinical investigation.
In the next five years, we plan on applying our attractor models to help understand and control two inter-
playing biological processes involved in many diseases: angiogenesis and hematopoiesis. Angiogenesis is the
development of new blood vessels and is required for embryonic development, adult vascular homeostasis, and
tissue repair. Our goal in angiogenesis is to identify organ-specific signals, which will provide new opportunities
to design new therapeutics to stimulate or inhibit angiogenesis in diseased organs (e.g., retinas of patients
suffering from age-related macular degeneration) without affecting healthy organs. In hematopoiesis, we will use
our computational approaches to identify new schemes to generate lymphocytes from induced pluripotent stem
cells (iPSC). The bio-manufacturing of iPSC-derived lymphocytes is important for many applications, such as
effective production of T cells for CAR-T therapies and development of cancer vaccines.
The new targets and target combinations identified by our in-silico experiments could lead to novel
therapeutics for many diseases, including cancer, blindness, arthritis, psoriasis, and many other ischemic,
inflammatory, infectious, and immune disorders. Just as important, this MIRA project will allow us to continue
working with our network of collaborators, keep sharing innovative software tools with the broader biomedical
community, and further contribute to the training of an interdisciplinary health sciences workforce with strong
computational and mathematical skills.

Public health relevance
NARRATIVE High-throughput single-cell RNA sequencing offers unprecedented opportunities for understanding the biology of cell differentiation. This project will use single-cell data in in-silico experiments to identify new drug targets and generate new hypotheses for pre-clinical investigation. Our goals are: (1) control of angiogenesis, a process involved in many ischemic, inflammatory, infectious, and immune disorders, and (2) new schemes for direct reprogramming of lymphocytes from induced pluripotent stem cells.